Signaling Mechanisms in Lens Development

PROJECT SUMMARY
Defective lens development is a major cause of congenital eye diseases, because the human lens is the
culmination of elaborate cell proliferation, differentiation and morphogenesis, requiring precise regulation by
signaling pathways. A molecular understanding of lens development could potentially lead to new ways of
diagnosing and treating congenital eye diseases originating from defective lens genesis. We have previously
demonstrated that Shp2 protein tyrosine phosphatase and Crk adaptor proteins are important for transmitting
FGF signaling in lens morphogenesis. In this application, we will investigate the molecular mechanism of Shp2
and Crk functions. Using conditional mutant mice and cell culture models, we will also identify Abl kinases as
novel negative regulators of FGF signaling. Furthermore, we will test the hypothesis that FGF signaling,
mediated by Crk, regulates the separation of the lens from the surface ectoderm, which underlies the human
congenital disease, Peter’s anomaly. As a major signaling pathway, perturbation in FGF signaling can cause
not only congenital diseases, but also metabolic syndromes and cancer. Therefore, study of FGF signaling has
far reaching implications for both human health and vision research.

Public health relevance
PROJECT NARRATIVE The genetic bases of many ocular syndromes remain unresolved, due to our limit in understanding the mechanism of lens development. This study has the potential to identify the molecular mechanism of FGF signaling in orchestrating lens morphogenesis. Such an understanding will help to guide our efforts in treating ocular related birth defects.